Texas A&M Center for Environmental Health Research (TiCER)

Overall ABSTRACT
The vision for the Texas A&M Center for Environmental Health Research (TiCER) is to nucleate
environmental health research and translational activities of investigators around the overarching theme
“Innovative solutions for addressing exposure-stressor interactions” with a focus on underserved populations in
urban and urbanizing areas in the state of Texas. This vision will be achieved by building on Texas A&M
University’s ongoing investments in people and facilities and a history of state-wide outreach to community
stakeholders, which synergizes the Center’s overall goals of reducing and preventing environmental health
disparities through basic, applied and community-engaged research. Existing investments through the Center
provide infrastructure and an outstanding base of scientific expertise ready to catalyze innovative studies into
environmental health concerns of affected communities, build multi-disciplinary collaborations among Center
members to elucidate mechanistic links between environmental exposures and adverse health outcomes and
ultimately translate data to action. The Center will continue recent successes in mentoring junior faculty,
advancing career development and leadership opportunities, recruitment of additional established investigators
into environmental health research, and fostering a multi-disciplinary, team-oriented intellectual environment
among Center members representing 11 colleges at Texas A&M. The Center’s vision is guided by four research
themes spanning fundamental and applied research to inform policy and public health: 1) Climate Change and
Health; 2) Environmental Justice and Policy; 3) Stressors to Responses; 4) Environment and Metabolism , which
will be coordinated through a highly integrated set of Facility Cores. The Translational Research Support Core
(TRSC) will support bi-directional translational workspaces including in vitro and in vivo model development and
toxicology and exposure science resources to ensure Center member access to unparalleled instrumentation
and cores. Together with the Data Science Core, these resources will enhance the capacity, breadth,
collaborative nature, and impact of environmental health research. The Administrative Core and Pilot Project
Program will facilitate TiCER’s function by ensuring continuation of the highest levels of institutional support,
fostering career development, and promoting multi-disciplinary team science that generates knowledge to action
in areas of community concern. The Community Engagement Core will be a critical vehicle for implementation
of a multi-prong strategy of the Center by serving as a bi-directional portal to connect Center members, affected
communities and key stakeholders. These efforts build on the strong tradition and engagement of Texas A&M
in public and community service statewide, emphasizing TiCER’s focus on environmental health disparities of
underserved populations. Overall, the Center will expand the established investigator base and expertise in
cross-cutting environmental health science that can be deployed to increase the impact of environmental health
research change in Texas and beyond.

Public health relevance
Overall NARRATIVE The vision for the Texas A&M Center for Environmental Health Research (TiCER) is to nucleate environmental health research and translational activities of investigators around the overarching theme of “Innovative solutions for addressing exposure-stressor interactions with a focus on underserved populations in urban and urbanizing areas” in the state of Texas. Overall, the Center will expand the established investigator base and expertise in cross-cutting environmental health science that can be deployed to increase the impact of environmental health research change in Texas and beyond.